Rapid detection of CRLF2 rearrangements in Hispanic Ph-like ALL patients to access diagnosis and relapse

The instructions from FOA PA-21-071 indicate that “At a minimum, the Research Strategy
section should be completed and must include a summary or abstract of the parent award or
project. Other sections should also be included if they are being changed by the proposed
supplement activities.”
The Project Summary/Abstract will not be changed as a result of the activities associated with
this supplement.

Public health relevance
The instructions from FOA PA-21-071 indicate that “At a minimum, the Research Strategy section should be completed and must include a summary or abstract of the parent award or project. Other sections should also be included if they are being changed by the proposed supplement activities.” The Project Narrative will not be changed as a result of the activities associated with this supplement.